An Integrated Isothermal Nucleic Acid Test for Improved Sickle-Cell Diagnosis at the Point-of-Care

Abstract
Sickle-cell disease (SCD) is a life-threatening inherited blood disorder of the !-globin gene that affects over 300,000
newborns globally each year, over 90% of which occur in low- and middle- income countries. Early childhood mortality
has been virtually eliminated in high-resource settings through the establishment of newborn screening programs that
enable timely diagnosis and treatment. In contrast, up to 90% of affected infants born with SCD in low-resource
settings will die before age ﬁve without ever receiving a diagnosis. Current diagnostic methods are expensive
and require laboratory equipment and trained personnel, making them ﬁnancially and technically inaccessible to the
countries with the greatest burden of SCD. The development of a rapid, low-cost, and easy-to-use diagnostic
test that can be implemented at the point-of-care (POC) could enable early diagnosis and prompt initiation of
preventative treatment, potentially saving the lives of over 50 million infants born with SCD by 2050. Many in-
expensive protein-based methods have been developed and piloted, but lack of sensitivity in the presence of high fetal
hemoglobin, poor speciﬁcity in patients recently transfused, and lack of interpretability make these tests ineffective
for newborn screening in settings that lack resources for conﬁrmatory testing. Advances in isothermal ampliﬁcation
techniques and inexpensive paper- and plastic- based diagnostic platforms offer an opportunity to overcome existing
limitations through the development of a DNA-based diagnostic that identiﬁes the mutation in the !-globin gene encod-
ing for sickled hemoglobin in an accurate, low-cost format that can be used in low-resource settings. In collaboration
with an industrial partner that specializes in developing low-cost diagnostic platforms, Axxin Pty. Ltd., and a sponsor
team based at Rice University and Texas Children's Hospital that specializes in POC diagnostic development, pediatric
hematology, and evaluating technologies in low-resource settings, I will develop a novel, inexpensive (<$3/test),
DNA ampliﬁcation test to detect the point mutation responsible for SCD on an integrated platform, and eval-
uate its performance and clinical utility in a low-resource setting. To accomplish this goal, we aim to (1) design
and optimize a multiplexed isothermal ampliﬁcation assay with lateral ﬂow detection to detect and differentiate the
genes encoding for normal and sickled !-globin chains, and integrate the assay into a paper- and plastic- cartridge;
(2) develop a sample preparation procedure that is compatible with downstream ampliﬁcation for a simple sample-
to-answer workﬂow; and (3) evaluate performance and clinical utility in two pilot studies — one in Houston, TX and
one in Lilongwe, Malawi. Completion of these aims will expand the ability of isothermal ampliﬁcation methods
to detect point mutations in DNA, provide the ﬁrst demonstration of an integrated paper- and plastic- based
nucleic acid ampliﬁcation test in a low-resource setting, and provide proof-of-concept data for a DNA-based
approach to diagnosing SCD. The technology developed can be used as a platform to incorporate point-mutation
detection of other hemoglobinopathies that contribute to SCD, and enable the development and implementation of a
scalable, inexpensive diagnostic test that is a critical step towards reducing early childhood mortality from SCD.

Public health relevance
Project Narrative Sickle-cell disease is a devastating genetic blood disorder that disproportionally affects low- and middle- income countries; without early diagnosis and treatment, the vast majority of infants born with sickle-cell disease in these countries will not survive to their ﬁfth birthday. Newborn screening programs and preventative treatment could save an estimated 9 million lives by 2050 — however, a major barrier in implementing and sustaining newborn screening programs for sickle-cell disease in low-resource countries is the lack of an affordable and effective diagnostic test that can provide results at the point-of-care. This proposal will develop and evaluate a novel DNA-based approach that combines isothermal ampliﬁcation with lateral ﬂow detection in an accurate and low-cost test, which could improve access to newborn screening and signiﬁcantly decrease under-ﬁve mortality due to sickle-cell disease.